Dusp4 in the pathogenesis of LMNA cardiomyopathy

DESCRIPTION (provided by applicant): Laminopathies are a diverse group of diseases arising from mutations in LMNA that encodes the A-type lamins A and C. Mutations in LMNA lead to tissue-selective diseases, the most common of which is dilated cardiomyopathy (LMNA cardiomyopathy). There is a dearth of insights into mechanisms by which mutations in LMNA cause dilated cardiomyopathy. Due to this fact, there is no specific therapeutic intervention that improves cardiac performance or prevents heart muscle deterioration. My overall goal is to reveal mechanistic insights into LMNA cardiomyopathy and, based on the new knowledge, develop mechanism-based therapeutic strategies. To this end, I have already made significant inroads into this goal, by identifying Dusp4 as a mediator of LMNA cardiomyopathy. One of the main objectives of this project is to extend on my findings and cover gaps in our current understanding of the Dusp4-mediated pathogenic mechanisms that drive LMNA cardiomyopathy. The proposed aims will take a multidisciplinary approach, spanning molecular and biochemical analyses to in vivo mouse genetics and live animal studies, with the ultimate goal of rapidly translating the gained knowledge into new clinical practice. Another main objective of this project is to continue my development as an independent scientist capable of conducting high quality multidisciplinary research. This entails two major areas of training: 1) additional scientific training through my mentor, co-mentors, didactic courses available at Columbia University, and attending national meetings and 2) career developmental training through grant writing workshops, courses in responsible conduct of research, conflicts of interest, manuscript preparation and presentation workshops, and lab/budget management. The collective training I will receive will help me attain my goal of finding a faculty position and establishing my own independent research program by successfully competing for RO1 funding. My short-term goals are to: 1. Identify pathogenic mechanisms mediated by Dusp4 in LMNA cardiomyopathy. 2. Continue my scientific and career development through my mentor, co-mentors, and didactic courses. 3. Advance my career by securing an independent faculty position and expanding my network of colleagues. My long-term goals are to: 1. Continue my scientific work, devise and perform preclinical studies based on new results obtained. 2. Attain RO1 funding, establish independent research program, and continue career development training. 3. Translate our findings into new therapies, train future mentees, and maintain successful research program.

Public health relevance
PROJECT NARRATIVE Dilated cardiomyopathy arising from mutations in the LMNA gene is a highly deadly disease with little understanding of the pathogenic mechanisms involved. We identified Dusp4 as a mediator of LMNA cardiomyopathy and this project aims to elucidate its role in the disease pathogenesis. As no specific treatment currently exists to treat LMNA cardiomyopathy, understanding the molecular mechanisms involved will lead to novel mechanism-based therapies to treat LMNA cardiomyopathy and perhaps, other forms of cardiomyopathy. __SpecificAimsTextDelimiter__ Specific Aims: Mutations in the lamin A/C gene (LMNA), encoding A-type lamins (lamin A/C), cause a diverse range of diseases collectively called laminopathies. Although A-type lamins are expressed in most differentiated mammalian somatic cells, specific mutations in LMNA lead to tissue-selective diseases, the most common of which is dilated cardiomyopathy (herein referred to as LMNA cardiomyopathy) with variable skeletal muscle involvement. The pleiotropic nature of laminopathies, as well as the molecular pathogenesis of specific diseases such as LMNA cardiomyopathy, is poorly understood. My long-term goal is to understand how specific mutations in LMNA cause tissue-selective diseases with cardiomyopathy as my primary model and to develop treatment for this life threatening disease. I hypothesize that LMNA mutations, causing abnormalities in the nuclear lamina, lead to dysregulation of signaling pathways that underlie disease pathogenesis. As no specialized treatment exists for LMNA cardiomyopathy, elucidating dysregulated signaling pathways underlying disease pathogenesis will result in identification of new druggable targets. In this regard, I have observed hyperactivated AKT/mTOR signaling and impaired autophagy in hearts of LmnaH222P/H222P mice, a model of the disease, and that blocking mTOR enhanced productive autophagy, ameliorating cardiomyopathy. I further discovered that Dusp4, an ERK1/2-inudced nuclear phosphatase that feeds back to quench ERK1/2 signaling, links LMNA mutation to AKT/mTOR. Hearts with Dusp4 overexpression displayed activated AKT/mTOR signaling with altered cardiac metabolism indicative of increased glycolysis and glycogen storage. Virtually nothing is known regarding how lamin A/C mutation elicits Dusp4 overexpression and the pathogenic mechanisms engendered by Dusp4. My primary goals are to understand how mutations in LMNA cause Dusp4 overexpression and to identify functional consequences of Dusp4 overexpression in the development of cardiomyopathy. To achieve these goals, I propose the following aims: K99 Aim 1: How does Dusp4 contribute to the pathogenesis of LMNA cardiomyopathy? I recently generated transgenic mice with cardiac-specific overexpression of Dusp4, which display features of cardiomyopathy and molecular signatures similar to the LmnaH222P/H222P mice. However, its functional contribution to cardiomyopathy is not clear. Therefore, I will test whether the phosphatase activity and the nuclear localization of Dusp4 are necessary prerequisites for disease pathogenesis. This will be achieved by generating transgenic mice with cardiac-selective expression of Dusp4 with either the phosphatase domain or the nuclear localization signal destroyed. I will also assess whether genetic deletion of Dusp4 in the LmnaH222P/H222P background ameliorates cardiomyopathy by crossing LmnaH222P/H222P mice with Dusp4-/- mice. These mice will also be used in experiments in Aim 3 (see below). K99 Aim 2: How do mutations in LMNA elicit Dusp4 overexpression? I hypothesize that mutations in LMNA cause Dusp4 overexpression. Based on the current literature, I suspect two known functions of lamin A/C are disrupted: its ability to maintain proper chromatin organization and its role as a molecular scaffold for signaling molecules such as ERK1/2. Therefore, I will test whether lamin A/C alterations cause epigenetic changes that facilitate transcription at the Dusp4 locus. I will study the interrelationship between the epigenetic status and the level of transcription factors that drive Dusp4 transcription. I will also test whether the ERK1/2:Dusp4 interaction, and hence ERK1/2 dephosphorylation, is disrupted by mutations in Lmna. R00 Aim 3: Elucidate pathogenic mechanisms elicited by Dusp4 overexpression. I will elucidate how Dusp4 activates AKT/mTOR signaling and explore specific pathogenic mechanisms fostered by Dusp4. I will explore the involvement of GSK3, a key regulator of glycogen synthesis. Given that the activation loop of GSK3 shares structural homology with ERK1/2, I hypothesize that GSK3 is a putative target of Dusp4 dephosphorylation. Lastly, I hypothesize that nuclear "leakage" of Dusp4 contributes to pathogenesis by dephosphorylating inappropriate cytoplasmic targets (i.e. GSK3). Transgenic mice with disrupted NLS generated in Aim 1, including others, will be used to test our hypothesis and to validate potential results. R00 Aim 4: Devise preclinical studies to treat LMNA-related and possibly other forms of cardiomyopathies. Based on the new knowledge gained, I will devise mechanism-based in vitro and in vivo preclinical studies to treat LMNA cardiomyopathy. I will also test the generality of Dusp4-mediated pathogenic mechanisms in other models of cardiomyopathy. Mouse models showing concordant pathogenic mechanism will be included in the preclinical studies to study the utility of the devised treatment strategy. The aims are novel and relevant to the mission of NHLBI. Effective treatment of LMNA cardiomyopathy will require mechanistic insight into the disease pathogenesis. The results from the proposed aims will broaden our scientific knowledge and potential therapeutic strategies for a disease that currently has no specific treatment.